Ion Channel Transporter Interactions

Project Summary
Voltage-gated potassium (Kv) channels, essential for cellular electrical activity, are generated by tetramers of
pore-forming α subunits, often in complexes with other, non-pore-forming β subunits and other protein classes.
Sodium-coupled solute transporters provide a mechanism for transport of water-soluble ions,
neurotransmitters, vitamins, sugars and other small molecules across cell membranes and against the
electrochemical gradient. In prior award cycles we discovered that Kv channels form physical complexes with
sodium-coupled solute transporters and we defined multiple modes of co-regulation in these “chansporter”
complexes, establishing a new class of cellular signaling hub. Concomitant with this work, we discovered a
range of novel small-molecule modulators of Kv channels and chansporter complexes, including synthetic
compounds and plant metabolites, some with therapeutic potential. In this latest cycle, we propose to pursue
both these fields of study, focusing primarily on the Kv1 (KCNA) and Kv7 (KCNQ) Kv channel families,
disruption of which causes disorders as diverse as ataxia, cardiac arrhythmia, diabetes, achlorhydria,
hypothyroidism, and epilepsy, and the transporters with which they interact. We will build on our prior work and
preliminary data that include novel chansporter complexes, novel modes of Kv channel chemosensing in
chansporter complexes, and screening results revealing abundant new Kv channel modulators from plants. We
have established two new, unpublished transgenic rodent lines for this project that will facilitate study of new
therapeutic approaches to treat Episodic Ataxia 1 (EA1) (a mouse model), and of the precise roles in vivo of
KCNQ5 and KCNQ5-transporter complexes (a Kcnq5 knockout rat line). We use a highly integrated approach
to investigate the molecular mechanistic bases for channel and chansporter biology and pathophysiology,
drawing from our long experience in studying molecular basis of biology and disease in multiple tissues,
cellular electrophysiology, transport and radioligand assays, transcriptomics, various imaging modalities,
structure-function studies, and biochemical techniques. In the next five years, we aim to address several
critical knowledge gaps, pursuing the following novel research directions: (1) Molecular mechanistic studies of
new and known channel-transporter complexes to dissect novel forms of co-regulation and signaling; (2)
Channel/transporter-active small molecule discovery from plants, drawing from our completed dual-target
screen of 1444 plant extracts; (3) elucidation of novel roles for KCNQ5 in the vasculature and brain; (4) in vivo
testing of the first compounds known to directly rescue EA1-linked Kv1.1 sequence variants. Our overarching
goals are to uncover new chansporter complexes and their roles in vivo, enhance understanding of Kv channel
biology, and discover novel and therapeutically relevant channel/transporter-targeted small molecules. This
supplement application is for the purchase of an automated patch clamp rig to greatly speed, enhance
physiological relevance of, and add other capabilities to the electrophysiological studies in the parent project.

Public health relevance
The supplement instructions PA-20-272 state: “At minimum, the Research Strategy section should be completed and must include a summary or abstract of the funded parent award or project. Other sections should also be included if they are being changed by the proposed supplement activities.” The original Project Narrative document has not changed as a result of the proposed supplement activities.